In situ investigation of bacterial secretion systems using cryo-electron tomography

PROJECT SUMMARY
Bacterial secretion systems encompass a wide range of macromolecular nanomachines which are involved in
a variety of functions crucial for cell viability. Despite their significance, our understanding of how the majority
of secretion systems known to date are built and function inside a bacterial cell remains limited. In part, the
latter is caused by the lack of high-resolution structural information pertaining to intact cells. At our lab, we aim
at utilizing cutting-edge microscopy techniques, such as cryo-electron tomography (cryo-ET), and a number of
other associated methodologies, to study the assembly, disassembly, and function of bacterial secretion
systems. Those techniques enable direct visualization of macromolecular complexes within intact, hydrated-
frozen bacterial cells at nanometer resolution. As a start-off, we will focus on the following two specific
secretion systems: 1) the bacterial motility nanomachine, the flagellar motor (an example of type III secretion
system), and 2) the type IV secretion system (T4SS), the latter being involved in a wide range of processes
such as secreting effector proteins and genetic material transfer between bacterial cells (bacterial conjugation).
Using cryo-ET, we will unveil the mechanism of how exactly bacteria assemble their seemingly complex
flagellar motors in stepwise fashion, and how they disassemble them under harsh environmental conditions to
save energy. Jointly utilizing cryo-ET and cryo-light microscopy, we will subsequently decipher the role of the
T4SS in the process of intercellular DNA transfer, visualizing the accompanying T4SS structural changes. The
results of our studies will deepen the understanding of how, in general, macromolecular complexes assemble
and perform their functions under various environmental conditions.

Public health relevance
PROJECT NARRATIVE Bacterial secretion systems represent a set of fascinating nanomachines involved in a variety of crucial functions, such as, e.g., cell motility, or secretion of substances into the outer milieu. The proposed studies seek the understanding of how those systems assemble, disassemble, and function, using cutting-edge electron microscopy methods. The proposed research program will shed light on how macromolecular machines function and evolve, enabling us to better control bacteria in health and disease.